Admin Core

A multi-institutional, international, and integrated endeavor, the “KS in the Era of ART in Africa Program
(KEAAP)” will leverage the research and training expertise of collaborating institutions from the U.S. and two
African countries: the Louisiana State University Health Sciences Center-New Orleans (LSUHSC-NO), the
Cancer Diseases Hospital (CDH) and the University Teaching Hospitals (UTH) of Zambia, and the Ocean
Road Cancer Institute (ORCI) in Dar es Salaam, Tanzania to form an HIV-Associated Malignancy Research
Center (HAMRC) that focuses on the research gaps of the Kaposi sarcoma (KS) disease. Building on the
success of their previous collaborations, these institutions will synergize their efforts under one overarching
research theme that focuses on the KS disease spectrum, from detection, to care and outcomes, to
deciphering KS pathogenesis and immune response. The immediate goal is to 1) implement a program to
better integrate KS diagnostic, clinical and research activities within the HIV-1 care and treatment networks in
both countries; 2) define stage- and treatment-associated immunologic and metabolomics biomarkers across
the spectrum of KS disease presentation; and 3) define the magnitude and breadth of Kaposi sarcoma
herpesvirus (KSHV) latent viral reservoirs in tissues of KSHV infected people living with HIV, so that these
reservoirs could be targeted for prevention of viral reactivation to prevent KS. To achieve this goal and promote
synergy and coordination across partnering institutions, KEAAP will establish an Administrative Core, based at
LSUHSC-NO with satellite locations at UTH/CDH, and ORCI, that will provide the administrative support
needed to ensure that KEAAP’s three research projects, Shared Resource Core (Data Management and
Integration Core), and Career Development Core can accomplish their individual and collective goals while
functioning in an integrated and coordinated manner. The Administrative Core will pursue four specific aims.
1) Provide the administrative expertise and resources necessary to support the consortium’s research projects
and cores and the pilot projects to accomplish their goals and specific aims. 2) Implement a consortium-wide
series of operational processes designed to create a collaborative research environment, promote data sharing
and dissemination of results, and build capacity for increased self-sufficiency at cancer research institutions in
Tanzania and Zambia. 3) Provide communications infrastructure to engage key stakeholders, to promote the
consortium, and disseminate information and research outcomes that will inform healthy policy changes locally,
and globally. The organization of the Administrative Core is designed to be responsive, inclusive, and robust –
attributes that are essential to address the broad mission and complex relationships within KEAAP, among
collaborating institutions, and with NIH. The core will focus on meeting the needs of the collaborators in a
climate of rapidly changing scientific and technological advances in order to promote a sustainable consortium
with vibrant research programs that work toward the reduction of cancer in sub-Saharan Africa.

Public health relevance
NARRATIVE A multi-institutional, international, and integrated endeavor, the proposed “KS in the Era of ART in Africa Program (KEAAP)” will leverage the research and training expertise of four collaborating institutions – the Louisiana State University Health Sciences Center-New Orleans, the University Teaching Hospitals and the Cancer Diseases Hospital in Lusaka, Zambia, and the Ocean Road Cancer Institute in Dar es Salaam, Tanzania – to conduct cutting edge research and capacity building activities that will lead to enhanced research infrastructure in Tanzania and Zambia and improve our understanding of one of the most prevalent HIV-associated malignancies, the Kaposi sarcoma. To promote synergy and coordination across partnering institutions, KEAAP will establish an Administrative Core that will provide day-to-day administrative support and resources, implement a consortium-wide series of operational processes, and provide communications infrastructure to engage key stakeholders and disseminate information about the consortium locally and globally. The core will focus on meeting the needs of the partnership and collaborators in the current climate of rapidly changing scientific and technological advances, which will result in a sustainable consortium with vibrant research programs that work toward the reduction of cancer in sub-Saharan Africa.